AI-based AML risk stratification using next generation cytogenomics

ABSTRACT
Chromosome aberrations are a hallmark of acute myeloid leukemia and offer mechanistic and
prognostic insights into disease. As such, a combination of cytogenetic assays are routinely applied as a part
of the AML diagnostic workflow. While offering invaluable information on disease severity, most chromosome
aberrations fall into the “cytogenetic abnormalities not classified” or “complex karyotype” categories. A range
of studies have shown that, while ambiguous, these variants have prognostic value, suggesting the existence
of cryptic variants of significance or complex epistases that drive the AML phenotype. However, there is
currently no system for translating genome-wide chromosomal aberration information into patient risk.
To improve the predictive potential of chromosome aberration profiles, we propose the development of
a risk-prediction metric that will add new prognostic value to AML studies. Specifically, we will produce a
method which will establish a patient risk metric that can help guide treatment decisions for patients
traditionally judged as of intermediate risk. This development will employ our scalable cytogenomic tools and
novel machine learning analytics to generate a large collection of cytogenomic datasets and analyze them to
identify patterns linked to AML phenotypes. Once completed, we will have a combined kit and software
solution that will not only improve upon existing cytogenetic applications in AML, but will offer new prognostic
insights beyond what is possible with current tools. This product will deliver high-resolution view of the
chromosome aberration landscape in AML and an offer a data-driven interpretation of how variants will impact
disease severity.

Public health relevance
NARRATIVE Chromosomal aberrations are essential biomarkers used to guide treatment decisions for acute myeloid leukemia patients. In this proposal we describe the use of a comprehensive method to assay chromosome aberrations at high resolution and use this information to more accurately predict the severity of disease. This information will potentially be helpful guiding decision making when making treatment decisions for patients poorly stratified by current methods.